RANDOMIZED, CONTROLLED TRIAL OF HEPARIN IN ULCERATIVE COLITIS

Randomized, controlled trial of Heparin in ulcerative colitis: 6-12 week trial with close monitoring for complications; open-labeled compassionate use arm available for non-responders.